Clinical Studies Investigating Use of the Bionic Pancreas in Pregnancy

ABSTRACT
While the use of intensive insulin therapy has reduced maternal and fetal mortality associated with type 1 and
type 2 diabetes in pregnancy, the risk of diabetes-related pregnancy morbidity remains high. Rates of pre-
existing diabetes in pregnancy in the United States have increased 30% over the past 5 years, driven by a
dramatic increase in the prevalence of type 2 diabetes in the obstetric population. The risk of pregnancy
complications in diabetes is directly related to hyperglycemia; thus, guidelines recommend lower glycemic
targets in pregnancy than outside pregnancy. However, these intensified pregnancy targets are extremely
difficult to attain due to the risk of hypoglycemia, dynamic changes in insulin resistance across gestation, and
the constant vigilance required for intensive insulin self-management during pregnancy. Unfortunately,
pregnant individuals have been systematically excluded from trials of novel automated insulin delivery systems
that have the potential to address the challenges of glycemic management and improve outcomes in diabetes-
affected pregnancy.
The iLet Bionic Pancreas is an FDA-approved automated insulin delivery system that improves glycemic
control and reduces the burden of diabetes management in people with type 1 diabetes. The device is
distinguished from other available systems because it is initiated with only the patient’s weight and eliminates
the need for carbohydrate counting or user-initiated correction boluses. However, like all other available
automated insulin delivery systems, the device was designed for a non-pregnant glycemic target range of 70-
180 mg/dl rather than the pregnancy glycemic target range of 63-140 mg/dl. We now propose to make
feasible modifications to the iLet device to achieve pregnancy-specific glycemic targets in type 1 and
type 2 diabetes. In Aim 1, we will conduct a 5-week crossover trial in non-pregnant individuals (N=20, 10 each
with type 1 and type 2 diabetes) to optimize iLet settings for the achievement of pregnancy-specific glycemic
targets. In Aim 2, we will compare optimized pregnancy-specific iLet settings to usual care in 36 pregnant
individuals (18 each with type 1 and type 2 diabetes) an 8-week random-order crossover trial.
These investigations will establish the first pregnancy-specific mode for a commercially available automated
insulin delivery system and will, for the first time, extend the use of automated insulin delivery in pregnancy to
individuals with type 2 diabetes. This work has the potential to transform the care of diabetes in pregnancy and
substantially improve maternal and neonatal health outcomes for the almost 40,000 pregnancies affected by
type 1 and type 2 diabetes yearly in the United States.

Public health relevance
NARRATIVE Pregnant people with type 1 and type 2 diabetes need to take insulin multiple times per day and control their blood sugars strictly to prevent serious pregnancy complications. This project will make changes to a new automatic insulin pump so that it can be used to lessen the burden of managing insulin and improve health outcomes in people with type 1 and type 2 diabetes during pregnancy.